Co-Design and Collaborative Development of an Imaging-Text-EHR Multimodal Foundation Model for Outcome Prediction of Critically Ill Patients

ABSTRACT
Mortality and morbidity are the most essential outcomes in patients admitted to the intensive care
unit (ICU). Timely prediction can aid clinicians in making treatment decisions, optimizing resource
allocation, improving outcomes, and managing patients’ and families’ expectations. Previously,
our research team developed a multimodal deep learning model predicting mortality and morbidity
among ICU patients by incorporating structured data (time-variant and time-invariant electronic
health record [EHR] data) and unstructured data (clinical text and chest X-ray images). In this
project, we aim to develop a multimodal foundation model that considers these three data
modalities: chest X-ray (imaging), clinical notes (text), and structured data (EHR). The foundation
model will then be fine-tuned to predict the probabilities of outcomes (mortality, morbidities, etc.)
after different periods of time (within 4, 12, 24, or 48 hours, for example). Explanation of the
predictions will be generated leveraging the multimodality of the model to help users assess its
trustworthiness. To ensure that the design will meet the needs of care providers and minimize
any ethical concerns, a co-design approach will be applied where clinicians, patient family
members, ethics experts, and computer scientists will collaborate and iteratively develop the
model using feedback from stakeholder engagement. The approach is divided into three tasks:
(1) stakeholder engagement to aid in ethical and model design; (2) development of multimodal
models, including using a foundation model architecture; and (3) external validation of models
and assessment of algorithmic bias. The model may serve as a generalizable architecture for
other multimodal models predicting clinical outcomes.

Public health relevance
Our proposed multimodal foundation models integrate imaging, clinical text, physiological data, and electronic health record data to improve prediction of critical illness outcomes in intensive care unit (ICU) patients. By enabling earlier identification of multiple ICU-related outcomes - from early mortality to long-term functional outcomes - this research has the potential to improve ICU decision-making, reduce morbidity and mortality, and enhance the delivery of precision critical care across diverse patient populations.